Resource and Service Section

PROJECT SUMMARY RESOURCE AND SERVICE CORE
The overall goal of the Resource & Service Core is to publicize the mice and services developed through the
JCPG to the broader scientific community. To accomplish this goal, the Core will work closely with the
Bioinformatics Core in the development of the JCPG website and portal to allow public access to resources
and tools. The distribution of mice will leverage the existing mouse production infrastructure at The Jackson
Laboratory (JAX) as well as the existing NIH-funded Mutant Mouse Resource and Research Center (MMRRC)
for a seamless transition of models from the core to the community. The Core will add new services and refine
existing service to ultimately develop into a fee for service program that operates in professional service
environment, with customer quotes, project execution, deliverables, finalized reports and feedback.
JAX has an almost 90-year history of developing, archiving, and distributing laboratory mice, and their
derivative resources and information, to the scientific community. The JCPG will complement and expand
resource stewardship at JAX by leveraging the deep expertise of JAX researchers and services.
JAX is seeing a predictable demand for model generation services as a result of CRISPR/Cas9 genome
editing technologies and the reduction in costs for patient sequencing. This, in turn, has increased the demand
for phenotyping and ancillary services, such as histology, gene expression, microscopy, etc. that can be
tailored for each disease model. Another growing demand that the JCPG will help to satisfy is the need for
pharmacology and efficacy-based preclinical testing in mice.
Operation of the JCPG Resource and Service Core will serve to: 1) Provide new mouse models to the scientific
community, following well-established processes for, rigor, quality assurance and customer service. Mice
generated by the Disease Modeling Unit (DMU) will pass seamlessly through our customer service and
production infrastructure to the JAX-MMRRC repository for maintenance, distribution and preservation. Each
step of the process will be facilitated by tools and processes developed by the Bioinformatics section of the
JCPG. 2) Refine existing and consider new key JAX services with input from our clients and make them
available to the biomedical community on a fee-based mechanism with a focus on maximizing awareness and
external availability using existing JAX outreach and marketing infrastructure and efforts. 3) Develop an
integrated management and operational structure that weaves together core services and delivers them as
efficiently as possible. Successful implementation of the Resource/Services core depends on our experienced
management team to integrate individual service cores into a seamless program.